Building Interdisciplinary Research Careers in Women's Health (K12) - BIRCWH administrative supplement

7. Project Summary/Abstract
Duke University and North Carolina Central University (NCCU), a historically Black institution, are applying for
support of a 4th BIRCWH scholar to join our 3 current BIRCWH scholars. Our program is grateful for the funding
that Congress allocated for this purpose (NOT-OD-22-180 Notice of Special Interest: Administrative Supplement
to BIRCWH). The 4th scholar we selected is a woman from a group underrepresented in the biomedical, clinical,
behavioral and social sciences as outlined in NOT-OD-20-031 Notice of NIH's Interest in Diversity. The
Duke/NCCU BIRCWH is a strong, vibrant program that has the leadership and institutional commitment required
for continued success. Our partnership, now in its 21st year, provides the foundation for a program that
encompasses interdisciplinary research, structured mentoring, and individualized career development for junior
faculty, with three major goals: (1) Develop highly skilled, innovative researchers who use interdisciplinary
approaches to investigate women’s health and sex/gender influences across the lifespan; (2) Foster diversity in
women’s health research and advance health disparities research affecting women’s health by identifying and
recruiting scholars from diverse backgrounds and (3) Enable and equip BIRCWH scholars to lead
interdisciplinary teams of scientists, and to become the mentors and leaders of the future. Adding the 4th scholar
to our group of 3 recently selected scholars results in a very diverse group of scholars with 3 of the 4 scholars
from groups underrepresented in the biomedical, clinical, behavioral and social sciences as outlined in NOT-OD-
20-031. Drawing on the breadth of expertise at our two universities, we have the capacity to advance the career
development of scholars interested in basic, clinical, or health services research across a broad range of fields.
Our scholars learn to integrate approaches to focus on women’s health and sex/gender differences in human
disease. Scholars’ interdisciplinary mentoring teams include a mentor from our core group of nationally known
senior investigators from Duke and NCCU, with others added to maximize interdisciplinary expertise and
collaborations. While our program usually spans 2 to 5 years, depending on each scholar’s career development
needs, the 4th scholar is funded for 2 years and will receive additional regulatory and research coordinator
support to finish her project under this accelerated timeline. Scholars perform intense, hands-on research; course
work; and training in grant writing, health disparities, team science, SABV and RCR. Each scholars’ progress is
monitored by the Leadership Team and the Internal Advisory Committee (IAC). The program is assessed and
advised by the IAC and an External Advisory Committee. At the completion of the program, scholars will become
leaders and mentors themselves. External evaluations of our program and scholars are performed by an
independent evaluator in the Duke Social Science Research Institute. The Duke/NCCU BIRCWH program is
achieving its goal to increase the size and influence of a diverse pool of highly trained women’s health
researchers who are poised to address the nation’s biomedical, behavioral, and clinical needs.

Public health relevance
Project Narrative Duke University, a major research university, and North Carolina Central University, a historic black university, both in Durham, NC partner for this career development program in women’s health research. Three selected junior faculty members from these two institutions will be joined by a 4th scholar to increase diversity in the biomedical workforce and all receive formal mentoring and training to conduct interdisciplinary research relevant to women’s health across the lifespan emphasizing health disparities and the effects that sex and gender have on health. These well trained scientists will be the future champions for improving women’s health nationwide and globally.